Exosomes as carriers of cancer therapeutics

Effective treatment of lung cancer remains a formidable clinical challenge. The advent of molecularly-
targeted therapies and immune checkpoint inhibitors has shown promise in lung cancer treatment. However,
only a subset of lung cancer patients benefit from these therapies. Further, inefficient delivery and
accumulation of anticancer drugs in tumor depots combined with dose-limiting toxicity contributes to disease
relapse, drug resistance, and metastasis culminating in patient death. As a result, the overall survival rate of
lung cancer patients is <16%. Thus, testing of new therapeutics and novel drug delivery systems that can
efficiently transport anticancer drugs to tumor depots and kill cancer cells are necessary for improving
treatment outcomes.
In the present application, we propose testing “exosomes” as drug carriers for cancer therapy. The
exosomes derived from normal human lung fibroblast and murine fibroblast cell-derived exosomes (Exo) are
loaded with iron-oxide nanoparticles (IONP) carrying an anticancer drug [Doxorubicin (Dox), Cisplatin (CDDP)].
The release of the chemodrug from the IONP is controlled by a pH responsive linker thereby minimizing drug-
related toxicity to normal cells. Further, the drug-IONP loaded exosome is decorated with a tumor-targeted
ligand for enhancing tumor-specific drug delivery and reducing cytotoxicity to normal cells. Finally, inclusion of
IONP enables monitoring tumor growth and treatment response by magnetic resonance imaging (MRI).
Pilot studies demonstrated exosomes could be successfully loaded with Dox-, and CDDP-conjugated IONP.
Further, excellent drug loading efficiency and drug release kinetics was demonstrated from the exosomes. In
vitro studies showed chemodrug-loaded exosomes exerted significant cytotoxicity towards cancer cells but not
normal cells. MRI and SQUID studies showed drug-loaded exosomes provided good contrast image without
losing the superparamagnetic properties of IONP. Furthermore, tumor-targeted (tt) exosomes directed towards
transferrin receptor (TfR) overexpressing lung cancer cells exhibited greater cytotoxicity compared to non-
targeted exosomes and accumulated in the tumor xenograft resulting in in vivo efficacy. Based on our
compelling preliminary data, we hypothesize that tt-exosomes will efficiently deliver chemotherapeutics to
tumor cells and concurrently enable measurement of treatment response by MRI with minimal toxicity to
normal cell when tested both, in vitro and in vivo. We will conduct the proposed studies under the following two
specific aims.
Aim 1a. Physico-biological characterization of tt-exosome as drug carriers for use in in vitro and in vivo studies.
Aim 1b. Determine the efficacy of tt-exosome against human and mouse lung cancer and normal cells,
spheroids and organoids in vitro.
Aim 2. Investigate the in vivo antitumor activity of tt-exosome against lung tumor models.

Public health relevance
Proposal Narrative Selective and effective delivery of anticancer drugs to in situ tumor will improve treatment outcomes. Herein, we are proposing to test exosomes as carriers of anticancer drugs for cancer treatment. Our preclinical studies will aid in advancing exosome-based therapy for future clinical testing.